Administrative Supplement for Structural Dynamics in Biology Resource Year 2

Project Summary – Administrative Supplement Request – 1P41GM139687-02 – Sebastien
Boutet (PI).
This administrative supplement request is driven by overall goals and aims of the Structural
Dynamics in Biology BTRR at SLAC National Accelerator Laboratory. The BTRR is aimed at
enhancing and developing the unique capabilities of the SLAC Linac Coherent Light Source
(LCLS) for biomedical applications. The requested supplement will support a broad user base
and further the goals of the DBPs and the TR&Ds.
By overcoming the limitations of radiation damage at the synchrotron, LCLS has been particularly
impactful in the study of large macromolecular machines that form small crystals with high solvent
content, making them delicate, difficult to cryo-preserve and extremely radiation sensitive. For
example, a major breakthrough was the application of SFX to examine crystals of intrinsic
membrane proteins, such as GPCRs, grown in LCP. GPCRs are the largest group of targets for
drug development, used to treat a wide variety of illnesses (e.g. cancer, cardiovascular disease,
and mental illness). LCLS is also impactful in the study of metalloenzymes, which are critical to
nearly all biological processes and as such represent a rich target space for therapeutics
development. High-resolution structural studies of metalloproteins are particularly challenging at
the synchrotron because the metal centers, especially those that are redox active, are very
susceptible to x-ray induced photoreduction. Further, the ultrafast (~40 fs) x-ray pulses produced
by the LCLS open new possibilities in directly observing dynamic processes involved in
macromolecular function. Moreover, many of the P41-derived developments that enable the rapid
collection of data using multiple small crystals, are applicable both at LCLS and at the synchrotron
to mitigate radiation damage. By expanding the capabilities at LCLS and at the SSRL synchrotron,
the BTRR opens more macromolecular machines to structural characterization, including time-
resolved studies over a wide range of biomedically relevant time scales. Integrating with, and
enhancing the existing programs at SSRL and LCLS, the BTRR will provide support, expertise
and training to the broad biomedical community.
This administrative supplement will enhance and expand the BTRR capabilities that are provided
to general users and to the P41 driving biomedical projects. The acquisition of a high speed x-ray
chopper will fill a critical need of the BTRR for efficient use of SSRL BL12-1 with small crystals
delivered by liquid/crystal injectors and for time-resolved measurements. In addition to achieving
microsecond time resolution, by breaking up the continuous x-ray beam into short pulses, the
chopper ensures crystals delivered by injectors are not destroyed by x-ray damage before they
are fully translated into the x-ray beam position, enabling exposure to unattenuated
monochromatic or pink-beam at BL12-1. In addition, this supplement requests a biocompatible
resin and ceramic 3D printer with 2-micron resolution that will allow for rapid prototyping and
optimization of sample injectors that will provide reliability and ease that will broaden the user
community. Finally, the proposal also requests a system to measure the conductivity of samples
in an automated manner which will allow to further the goals of the BTRR in characterizing sample
conditions and mapping those onto the ideal sample delivery method to be used for a given
sample, providing users with structured decision-making on how to best perform their experiment.
This will complement ongoing efforts in physicochemical characterization by adding conductivity,
an important parameter for electrokinetic sample delivery, to lookup tables to be published.

Public health relevance
Narrative Statement – Administrative Supplement Request – 1P41GM139687-02 The purpose of this P41 resource is to enhance and develop the unique capabilities of the SLAC Linac Coherent Light Source (LCLS) for biomedical applications. Combined with BTRR resources at the SSRL synchrotron, capabilities spanning a wide range of biomedically relevant time scales are provided, as well as support, expertise and training to the broad biomedical community. This administrative supplement will enhance and expand the BTRR capabilities for time-resolved measurements through the development of a high-speed x-ray chopper system for SSRL beam line 12-1 and by providing enhanced prototyping capabilities for novel sample injectors and enhancing the sample pre-characterization capabilities of the BTRR..